Admin Core

PROJECT SUMMARY/ABSTRACT
The Administrative Core (AC) has been critical to the continued success of the NORC at Harvard (NORC-H)
over the last cycle. The NORC-H has continued to fill major gaps in the promotion of nutrition and obesity
research at Harvard and its affiliate institutions. The AC facilitates the continued expansion of the NORC-H,
leveraging a strong membership, including an increased number of junior investigators, accomplished in
research across the translational spectrum, building a strong clinical and translational focus, and developing
state of the art core services, including genomic and single cell transcriptomic techniques, cell culture and
organoid services, mitochondrial functional assessment, model development, detailed metabolic assessment in
animal models, and highly sophisticated functional imaging techniques allowing investigators to probe human
metabolic pathways including appetite, substrate flux, and tissue specific inflammation. The goals of the
NORC-H AC are: 1) to provide an overall organizational structure with which to direct the NORC-H, including a
Director experienced in clinical and translational research and 4 strong Associate Directors (AD’s) with
complimentary expertise; 2) to capitalize on a strong Research Base in Nutrition and Obesity at Harvard and
affiliated hospitals, with themes in translational research; 3) To foster cutting edge research by enabling highly
successful and well used cores: Genomics and Cell Biology (GCB), Metabolic Phenotyping (MP) and Metabolic
Imaging (MIC) cores, leveraging the strengths at Harvard in these areas (including functional adipose imaging,
PET and Functional Neuroimaging (MI); and Metabolomics, Mitochondrial Function, Adipocyte Biology, and
Model Development (MP), next generation sequencing, single-cell profiling, high-content/high-throughput cell-
based assays, cell culture and organoids, and bioinformatics (GCB) demonstrating significant usage and
facilitating key publications; 4) To administer a vibrant P&F Program which has been a highly successful
component of the NORC-H fostering promotion of successful young scientists in the nutrition/obesity field,
leveraging pilot funds into significant NIH grant support, and catalyzing new collaborations in translational
science. 5) To administer a highly respected and popular enrichment program, including an Annual
Symposium on nutrition and obesity topics, responsive to changing research priorities, training the next
generation of scientists in nutrition and metabolism through coursework supported at the Medical School,
Harvard Chan School of Public Health, and mentoring of young trainees, via our annual P&F Symposium; 6)
To promote the advancement of URM’s in nutrition and obesity research, through funding an RFA and ongoing
efforts to increase P&F applications and success rates for URM’s, establishment of a Diversity Scholar
program to support a cadre of scientists to attend our enrichment events, a Diversity Mentoring Award, and
participation of the Director and Diversity Director, on the National NORC URiA Advancement Working Group.